TOPOLOGICALLY MODIFIED OLIGONUCLEOTIDES TARGETED TO HIV1

In this application the PI proposes to continue studies on topologically constrained oligonucleotides which are designed to bind to RNA or DNA. These oligonucleotides are capable of forming triple-stranded complexes with targeted nucleic acids and include circular oligonucleotides, stem- loop oligonucleotides, purine hairpin oligonucleotides, and cross-linked and bicyclic oligonucleotides. The specific aims of the proposal include: (1) Exploration of novel approaches to targeting structured nucleic acids; (2) Optimization of modifications for enhancing RNA-binding properties; (3) Evaluation of new synthetic approaches to topologically modified oligonucleotides; and (4) Collaborative testing of these new molecular strategies in HIV-infected cells. The long term objectives of the studies are to optimize the performance of synthetic oligonucleotides and to test them in applications directly related to HIV-1 infection. This includes both medical diagnostic and potentially therapeutic applications.